Eastern Mediterranean Partnership to implement the Regional Framework for Mental Health: Going to scale with school mental health

? DESCRIPTION (provided by applicant): An estimated 10-20% of children globally are affected by a mental health problem. Child mental health has been identified as a priority within the WHO's Eastern Mediterranean Region (WHO EMRO). Following consultations with international and regional experts and stakeholders, WHO EMRO developed an evidence-based manualised School Mental Health Intervention (EMRO SMHI), endorsed by all member countries, including Pakistan, where the federal and provincial health departments have made plans for phased national implementation at scale. A number of implementation challenges identified by stakeholders at a WHO EMRO consultation have to be addressed to achieve these plans, including sustainable delivery of quality training and supervision at scale; routine monitoring of outcomes; mechanisms for ensuring programme quality; and intervention adaptation for delivery in diverse regional settings. We will conduct research in Pakistan embedded within national implementation of the EMRO SMHI to address these challenges, applying scalable technological and social innovations developed and feasibility-tested in Pakistan. This builds upon many years' experience of successfully delivering similar programs in resource- poor and challenging community-based settings in this region of Pakistan. Capacity building will be embedded within the project with focus on child mental health. This will involve strengthening the capacity of targeted cohorts of researchers and policy makers in 4 EMRO countries (Pakistan, Iran, Jordan, and Egypt) to: 1) Develop skills in generating, applying and effectively disseminating research to aid implementation of school-based interventions for child mental health; and 2) To understand, interpret and apply science-based methods and information to develop child mental health policies and plans; 3) Use their skills to build the child mental health research and policy capacity of their countries and the region as a whole. The research component, consisting of two stages, will be embedded within Pakistan's phased scale-up implementation of the EMRO SMHI. Research will be conducted in Pakistan, in sites with an established research infrastructure, sub-districts Kallar Syedan and Gujar Khan, in the Province of Punjab. The research team will partner with the Pakistan Health Ministry and the WCC-IoP to both study and assist its scale-up plans by integrating our technological and social innovation. We will begin our work by engaging stakeholders to develop a comprehensive theory of change to both guide scale-up and support testable hypotheses about the structures, collaborations, and knowledge most important to the process of scaling innovations. In the next stage the research team will work with the WCC-IoP to conduct hybrid effectiveness-implementation research comparing two methods of implementing the EMRO SMHI. Using mixed methods, we will compare conventional training, supervision, service delivery and program monitoring with the use of a tablet-based technology-assisted platform that integrates these essential functions. The platform uses readily-adaptable video and audio modules to provide a structure for cascading personalised knowledge and skill instruction to teachers, so they can in turn apply universal and targeted strategies to address mental health problems with children and their families. We hypothesise that use of the platform will lead to improvements in both clinical and implementation outcomes.

Public health relevance
PUBLIC HEALTH RELEVANCE: An estimated 10-20% of children globally are affected by a mental health problem. Child mental health has been identified as a priority within the WHO's Eastern Mediterranean Region (WHO EMRO). Following consultations with international and regional experts and stakeholders, WHO EMRO developed an evidence-based manualised School Mental Health Intervention (EMRO SMHI), endorsed by all member countries, including Pakistan, where the federal and provincial health departments have made plans for phased national implementation at scale. A number of implementation challenges identified by stakeholders at a WHO EMRO consultation have to be addressed to achieve these plans, including sustainable delivery of quality training and supervision at scale; routine monitoring of outcomes; mechanisms for ensuring programme quality; and intervention adaptation for delivery in diverse regional settings. We will conduct research in Pakistan embedded within national implementation of the EMRO SMHI to address these challenges, applying scalable technological and social innovations developed and feasibility-tested in Pakistan. This builds upon many years' experience of successfully delivering similar programs in resource- poor and challenging community-based settings in this region of Pakistan. Network aims: This application aims to address school-based child mental health in the EMRO region by 1. Developing a collaborative network of institutions, researchers, policy partners and community stakeholders engaged in implementing child mental health with a focus upon the EMRO SMHI. 2. Build the network's capacity in implementation research to scale-up EMRO SMHI and other child mental health programs in their countries. 3. Conduct implementation research to scale-up EMRO SMHI in Pakistan, learning from which will be synergised to capacity building to translate research outputs to Iran, Jordan, and Egypt. Administrative core: To address these aims we will build upon a unique partnership of embedded regional policy bodies and national policy makers, researchers, and community-based NGO's. This regional network will work collaboratively with three international academic organisations providing technical expertise and support. The administrative core will be based in Pakistan at the WCC-IoP for Mental Health Research and Training, Rawalpindi (WCC-IoP). The WCC-IoP are ideally placed for this function, occupying a strategic policy development and implementation role, promoting the integration of research into policy through collaboration with government ministries, and with broad capacity building responsibilities. Capacity building: Capacity building will be embedded within the project with focus on child mental health. This will involve strengthening the capacity of targeted cohorts of researchers and policy makers in 4 EMRO countries (Pakistan, Iran, Jordan, and Egypt) to: 1) Develop skills in generating, applying and effectively disseminating research to aid implementation of school-based interventions for child mental health; and 2) To understand, interpret and apply science-based methods and information to develop child mental health policies and plans; 3) Use their skills to build the child mental health research and policy capacity of their countries and the region as a whole. Scale-up research: The research component, consisting of two stages, will be embedded within Pakistan's phased scale-up implementation of the school mental health program. Research will be conducted in Pakistan, in sites with an established research infrastructure, sub-districts Kallar Syedan and Gujar Khan, in the Province of Punjab. The research team will partner with the Pakistan Health Ministry and the WCC-IoP to both study and assist its scale-up plans by integrating our technological and social innovation. We will begin our work by engaging stakeholders to develop a roadmap to both guide scale-up and evaluate various approaches to intervention training, supervision and delivery. In the next stage the research team will work with the WCC-IoP to conduct an evaluation of two methods of implementing the intervention. Using different research methods, we will compare conventional training, supervision, service delivery and program monitoring with the use of a tablet-based technology-assisted platform that integrates these essential functions. We predict that use of the platform will lead to improvements in both clinical and implementation outcomes. We anticipate that the findings will lead to improved programs that can be delivered to many children across the region and the world.